Revision to the Coordinating Center for Type 1 Diabetes TrialNet

Project Summary/Abstract
This application requests support for the continuing operations of the TrialNet Coordinating
Center (TNCC) at the University of South Florida. The University of South Florida has served as
the Coordinating Center for TrialNet since October, 2008. The primary objective of TrialNet is to
prevent or delay initial onset and/or progression of type 1 diabetes (T1D) by preserving insulin-
producing beta cells in individuals at elevated risk and those who have been newly diagnosed
with T1DM. To achieve this goal, TrialNet designs and implements prevention and
interventional clinical trials intended to test treatments that may preserve remaining insulin
secretion in recently diagnosed individuals (new-onsets). The TNCC provides epidemiological,
biostatistical, operational and administrative expertise and advice to the clinical centers,
reference laboratories and the NIDDK which include the following tasks: 1) study-wide
communications, procurement and dissemination of study materials, and related activities 2)
data management and records maintenance; 3) clinical site and central laboratories monitoring;
4) data analyses; 5) preparation of study reports and papers for publication; 6) implementation
of procedures to evaluate management, methodology, and cost-effectiveness of procedures
utilized by the TNCC. This application provides support for the design and conduct of
prevention and recent onset trials. It provides for continued support for TrialNet and the many
ongoing projects focused on the identification of individuals at risk and their enrollment on
TrialNet studies.

Public health relevance
Project Narrative The goal of Type 1 Diabetes TrialNet is the prevention of type 1 diabetes in individuals at- risk for its development. Identification of individuals at elevated risk of developing the disease will provide more information about risk factors, leading to a better understanding of disease pathogenesis. The conduct of trials in individuals recently diagnosed with type 1 diabetes will provide important insights into the safety of new drugs and their ability to preserve insulin secretory capability. This proposal addresses support for the design and conduct of prevention and new-onset trials. It also provides support for a wide range of research projects in varying stages of development, implementation and completion. It will continue to fund and oversee the performance of TrialNet Clinical Centers. The application also includes continued support for the DCC's functions in support of TrialNet recruitment, enrolling at-risk individuals in intervention studies to test treatments intended to delay or prevent the onset of type 1 diabetes and enrolling newly diagnosed individuals in intervention studies to test treatments intended to preserve remaining insulin secretion that may result in new strategies to prevent, delay or reverse T1D. A better understanding of the characteristics or biomarkers that distinguish responders may allow more targeted intervention strategies. The TrialNet Coordinating Center will contribute to the design of TrialNet protocols. Funds are also requested for operations to maintain existing study protocols, provide project oversight, coordination, communication, statistical analyses, quality control and capability to collect longitudinal data and results of laboratory analyses of biological specimens from individuals at-risk for diabetes.